Regulation of Ciliogenesis and Ciliary-related signaling

In FY19, my laboratory further investigated the molecular pathways important for primary cilium assembly and signaling. These studies involved the characterization of proteins important in regulating membrane trafficking process in normal ciliogenesis and in ciliopathy. Laboratory projects overview: 1) We published our work on the F-BAR membrane reshaping protein PACSIN1 and -2 role in ciliogenesis. We used advanced cell biology approaches, in particular genetics and imaging to resolve the role of PACSIN proteins. Imaging studies included correlative light and electron microscopy (CLEM) and super-resolution SIM and STORM and focus ion beam scanning electron microscopy (FIB-SEM). Using genetic approaches we demonstrated that the PACSINs function at early stages of ciliogenesis, in particular the assembly of the ciliary vesicle. We also detected PACSIN1/2-positive membrane tubules associated with early stages of ciliogenesis. In collaboration with Dr. Kedar Narayan in the CCR Center for Molecular Microscopy (CMM) we used CELM FIBSEM to investigate the mechanism of membrane assembly during intracellular ciliogenesis. The findings from FIB-SEM have provided new insights into the process of intracellular ciliogenesis. First, we showed that membrane tubules are generated from the ciliary vesicle and intracellular cilia membrane. Second, we discovered that these membrane tubules locate and fuse with the plasma membrane, providing a mechanism for how the intracellular cilium emerges from the cell surface. We also discovered membrane tubule formation on the ciliary pocket membrane and showed that these are associated with the trafficking of ciliary cargo. We are continuing this project, following up on novel observations made by FIB-SEM related to how membrane structure regulates early stages of ciliogenesis. In particular, we are interested in the relationship between the developing ciliary membrane and uncapping of the mother centriole. 2) We published a manuscript describing the mechanism of cilium assembly initiation. The key findings from this work include the discover of ta Rab11-effector switch regulated by Akt signaling. In unciliated cells Rab11 interacts with its effector WDR44 in an Akt-dependent phosphorylation manner. In the absence of Akt, Rab11 switches to a Rabin8 effector complex which is important for initiating early ciliogenesis events at the mother centriole. We have subsequently demonstrated that another Rab11 effector FIP3 is essential for the switch to pre-ciliary trafficking. Our mechanistic understanding of this Rab11 effector switch was greatly enhanced by an important collaboration Dr. Esben Lorentzen at Max Plank. Revision experiments are underway. 3) We have submitted a manuscript examining the role of the TRAPP complex in ciliogenesis. We have discovered a novel TRAPPC protein, TRAPPC14, which regulates Rabin8 preciliary trafficking and which mediates interaction between Rabin8 and the larger TRAPPII complex. 4) In another project, we are characterizing a novel membrane fusion SNARE complex important for ciliogenesis. Cell biology and biochemical studies are ongoing to characterize the SNARE complex. Meetings and Presentations: ASCB December 2018 - poster presentation. FASEB Biology of the Cilia meeting August 2019 - Presenting a short talk on Akt regulation of ciliogenesis initiation and a poster describing Pacsin ciliogenic function. Invited talks were given at the University of Colorado Denver Department of Cell and Developmental Biology (August 2019), Department of Biochemistry and Biophysics UCSF (May 2019), Stanford University Department of Biology (may 2019), University of Pennsylvania Vision Research Center (March 2019), and Yale University Department of Molecular Cellular and Developmental Biology (December 2018),